A Clinical Trial of Cancer Prevention by Biomarker Based Detections of Barrett's Esophagus and Its Progression

Abstract
This Project aims to reduce mortality from Esophageal Adenocarcinoma (EAC) by pioneering two paradigm
changing approaches. First, we will demonstrate the efficacy of non-endoscopic biomarker-based early detection
of Barrett's esophagus (BE), in a population without symptoms of gastroesophageal reflux disease (GERD).
Second, we will establish a novel molecular technology, dubbed “BAD”, for early detection and interception of
BE progression toward EAC. BE is the precursor lesion of EAC, a cancer with 80% 5-year mortality. BE is
currently detected only when individuals with GERD undergo endoscopic (EGD) screening. Once detected, BE
patients undergo triennial surveillance EGD with random biopsies to catch progression to high-grade dysplasia
(HGD), that can be eradicated endoscopically to prevent cancer. Weaknesses of the approach include: i) low
acceptance of EGD screening among GERD patients; ii) the absence of any recommended screening among
non-GERD patients, who fall completely outside of BE screening guidelines, but who account for 40% of EAC;
frequent failure of random surveillance biopsies to detect early EAC, with many cancers arising in between
surveillance exams and others already metastatic when detected. Our team developed a novel swallowable
balloon-based device to enable targeted screening of the distal esophagus (the site of BE origin) in a simple 5-
minute office procedure. We mated this device with a methylated DNA biomarker panel that sensitively detects
BE. In the GERD population we showed this approach detects non-dysplastic BE (NDBE) with 90% sensitivity
and 92% specificity. We now find that non-GERD patients with 3 or more BE risk factors (age, obesity, smoking,
male sex, white race) have BE risk similar to GERD patients. Aim 1 of this proposal will conduct a human trial
demonstrating that our non-endoscopic biomarker-based technology will enable BE detection in this non-GERD
population, with positive predictive value greater than that of current guidelines for EGD screening of GERD
patients. Second, our group applied methods of deep DNA sequencing and AI analysis, developed for detecting
cancer DNA in liquid biopsies, to instead detect abnormal DNA from nascent clones of progressed BE captured
in esophageal brushings that comprehensively surveille the full BE disease segment. We showed this method,
“BAD”, detects as “Very-BAD” 97% of EAC and 68% of HGD. We also showed Very-BAD identifies a 7% subset
of non-dysplastic BE, that on retrospective review showed high risk of early progression to HGD or EAC. Aim 2
of this proposal will: i) implement improvements to the BAD methodology aimed at increasing sensitivity for HGD
to 85%, while preserving specificity; ii) prospectively demonstrate that Very-BAD NDBE defines a population with
high 3-year risk of BE progression to HGD; iii) implement BAD as a method to enable frequent non-endoscopic
BE surveillance by adapting BAD to work with samples from our non-endoscopic balloon device. Last, molecular
studies will determine the basis of false positive and false negative BE calls in non-GERD subjects, and will also
visualize and molecularly interrogate the early progressed BE cells that are detected as Very-BAD.

Public health relevance
Detection of its precursor Barrett's esophagus (BE) and interception of esophageal adenocarcinoma (EAC) is required for a cancer whose rate has more than sextupled in the past three decades. A two-step strategy consisting first of a non-invasive method that uses epigenetic biomarkers to detect BE will expand BE screening in patients with and without GERD. Subsequent surveillance of BE patients using molecular DNA based biomarkers that can risk stratify BE and prevent or detect early cancer would greatly decrease costs and could clinically impact the poor prognosis of EAC.